BIOPHYSICAL SOCIETY MEETING 2005

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The 2007 Biophysical Society meeting was held from March 4-6, 2007 in Long Beach, California. Nine NCRR resources will participate in the booth activities.